FLS MEASUREMENTS OF SINGULAR MOLECULES

We will be using FRET between two DAPI molecules in DNA for obtaining structural information. In addition FLIM of porphryns in cells will be evaluated as a measure of cell viability.